Chemoenzymatic Total Synthesis of Pentaene Antifungals and Analog Development

Project Summary/Abstract
Infections caused by the fungi Candida and Aspergillus affect more than one billion people each year. While
often not life threatening, these infections are much more severe when they become invasive. Invasive infections
are exceptionally deadly in patients undergoing chemotherapy or who are otherwise immunodeficient, and
current clinical methods for the treatment of invasive fungal infections are ineffective or cause complications due
to off-target toxicity. This results in an annual death toll exceeding 1.5 million. As such, the World Health
Organization (WHO) and the National Institute of Allergy and Infectious Diseases (NIAID) have identified
research supporting the development of novel antifungals as critically important. The research proposed in this
fellowship will leverage chemoenzymatic total synthesis to access pentaene antifungals in a concise and modular
manner. The central hypothesis of this research plan is that rational design of new analogs that can be accessed
only through chemical synthesis will afford antifungals that rival the current clinical standard. The proposed
synthetic strategy relies on an enzymatic aldol reaction, bidirectional chain extension, and desymmetrization to
deliver the all-syn backbone present in the filipins and pentamycin. Late-stage macrocyclization will avoid stability
concerns arising from the sensitive pentaene motif. Finally, chemoenzymatic oxidations will be performed to
deliver three different pentaene natural products. Furthermore, we propose a novel enzymatic mix-and-match
strategy to deliver different partially oxidized polyenes that are not produced in nature. This chemoenzymatic
approach will enable the development of analogs that contain modifications to hydroxyl groups along the polyol
backbone, or to the polyene motif. The first class of analogs is designed to probe hydrogen-bonding to enhance
ergosterol-binding selectivity and avoid human toxicity. The second class is designed to investigate π–stacking,
thereby modifying specificity and stability of the polyene antifungals. Finally, hybrid analogs that combine the
modifications present in both classes will be synthesized to access the ideal antifungal. All told, access to dozens
of analogs through the same route will elucidate structure–activity relationships and inform rational design of
new antifungals for the broader scientific community. The applicant’s long-term goals are to engage in research
at the interface of chemistry and biology to solve problems that are challenging to address with either discipline
independently. This fellowship will allow the applicant to further improve their skills in chemical synthesis while
learning new techniques in enzymology, biology, and medicinal chemistry. The fellowship will also strengthen the
applicant’s skills in mentoring, teaching, and communication so that they can have a successful independent
career training junior scientists in organic chemistry. This will provide young scientists with the toolset necessary
to work at the interface of organic chemistry and other impactful fields.

Public health relevance
Project Narrative Invasive fungal infections affect millions of patients worldwide and are more deadly in immunocompromised patients, including those with COVID, AIDS or undergoing chemotherapy. This research fellowship will generate new antifungal compounds by merging chemical synthesis with biological synthesis. Elucidation of structure–activity relationships will enable the development of new treatments for invasive fungal infections that may rival treatments in the clinic today.